SCH: SEEthroughGLAUCOMA: Smart Eye Emulator (SEE) to study glaucoma risk factors

PROJECT SUMMARY (See instructions):
Open angle glaucoma (OAG) is a leading cause of irreversible blindness worldwide with significant
disparities in prevalence, incidence, and progression depending on gender, race, and socio-economic
status. OAG risk increases with age and presents not only an increasing economic burden on health care
systems, but also a challenge in ensuring fair and equitable treatment approaches. Unfortunately, poor
understanding of OAG risk factors has constrained currently approved treatments to intraocular pressure
(IOP) reduction. Other factors such as vascular health, specifically blood pressure (BP), are known to alter
risk of OAG onset and progression. BP and IOP vary by person, with both high and low BP being
associated with the disease process. Thus, quantifying the relative contribution of BP as a risk factor in
combination with IOP for a given individual inclusive of other demographic disparity factors will produce a
translational framework to advance glaucoma management.
The main goal of this project is to develop an innovative method for interpreting weighted contributions of
IOP and BP, along with other risk factors such as age, gender and race. A significant outcome of this
research will be a framework to assist clinicians in directing care to those who need it the most while
preventing unnecessary treatments for those at lowest risk. The proposed method consists in: (i)
developing a fast and accurate emulator for estimating the physiological status of a person's eye based
on individual-specific values of BP and IOP (Smart Eye Emulator, SEE; Aim 1); (ii) developing a method
for Transfer Learning of patient clusters across diverse and heterogeneous datasets that leverages the
physiological-enhanced variables provided by SEE (physiology-enhanced data analytics; Aim 2); and (iii)
ensuring relevance of the project outcomes by incorporating dynamically the feedback of end-users on the
perceived usability and usefulness of the proposed approach in clinical practice (Aim 3). Our team
includes experts in ophthalmology, mathematics, statistics, computer science, and health communication
science who collaboratively are providing diverse multi-center datasets from multiple countries and
continents.
Ultimately, the outcomes of this project will provide new methods to quantify the relative weight of IOP and
BP in the disease process of each individual and will identify characteristics that put people at-risk for

Public health relevance
RELEVANCE (See instructions): Open angle glaucoma is a leading cause of irreversible blindness worldwide with significant disparities in prevalence, incidence, and progression depending on gender, race, and socio-economic status. The proposed research is relevant to public health because quantifying the relative weight of intraocular pressure and blood pressure in the disease process of each individual and identifying characteristics that put people at-risk for glaucoma, particularly racial and ethnic minorities, will promote better methods to